USES OF ARTIFICIAL INTELLIGENCE TO OPTIMIZE THE CANCER DRUG DEVELOPMENT PROCESS

Artificial intelligence methods and classical statistics are being applied, in combination, to the task of analyzing and optimizing the cancer drug development pipeline. The Anti-Cancer Agent Predictions Working Group (ACAP) has been formed to coordinate these efforts. initial results are as follows: (1) Development of neural networks (MecNet) capable of predicting mechanism of drug action on the basis of patterns of activity in the 60-cell line cancer drug screen; (2) Development of a program (DISCOVER) for identification of new structural and functional motifs among the tens of thousands of agents tested in the screen; (3) Use of clustering in combination with neural networks and discriminant analysis to identify candidate cell lines for replacement in the screen (by breast, prostate, target-selected, target-transfected, and non-malignant lines, as appropriate). (4) Preliminary predictions of the clinical activity of phase II-evaluable drugs on the basis of patterns of activity in the screen.